Activating Autophagy to Treat Uromodulin-Associated Genetic Chronic Kidney Disease

Uromodulin-associated genetic chronic kidney disease, or autosomal dominant tubulointerstitial kidney disease
caused by uromodulin mutations (ADTKD-UMOD), is a leading hereditary kidney disease and characterized by
renal fibrosis and progressive loss of kidney function. Currently there is no targeted therapy. To address the
unmet medical needs, by using CRISPR/Cas9, we have developed an ADTKD-UMOD mouse model carrying
Umod p.Tyr178-Arg186 del, the mouse equivalent of the most prevalent human mutation. Uromodulin (UMOD)
is mostly synthesized and secreted by the tubular cells of thick ascending limb (TAL). Linked with mutant
UMOD-triggered endoplasmic reticulum (ER) stress, our mouse model shows that autophagy and mitophagy
deficiency in TALs leads to increased accumulation of the toxic mutant UMOD aggregates and mitochondrial
DNA leakage-induced activation of innate immune signaling molecule STING (stimulator of interferon genes),
which cause TAL cell death and renal fibrosis in ADTKD. Most importantly, we have discovered a novel ER
soluble protein mesencephalic astrocyte-derived neurotrophic factor (MANF), which functions as a positive
regulator of autophagy/mitophagy. MANF tubular overexpression can decrease mutant UMOD accumulation
and counteract STING-induced inflammation, thus attenuating fibrosis and improving kidney function in our
mouse model of ADTKD. Our hypothesis is that restoring suppressed autophagy and mitophagy by targeting
MANF and its receptor is a novel therapeutic strategy to treat ADTKD-UMOD.
The overall goals of this proposal are to determine the molecular mechanisms underpinning the biological
and therapeutic functions of MANF, to develop MANF-based therapy, and to define the role of newly identified
MANF receptor neuroplastin in ADTKD. To accomplish our research goals, we have assembled an
interdisciplinary team including multiple Co-Investigators and cores with various innovative technologies and
required expertise.
The proposed study will provide critical insights into the molecular pathogenesis of ADTKD and develop
highly-targeted and mechanism-based novel treatments for ADTKD patients.

Public health relevance
Genetic chronic kidney disease due to uromodulin (UMOD) mutations, a leading hereditary kidney disease, is characterized by progressive renal fibrosis and renal failure. The goal of this project is to develop novel autophagy activators that target autophagy and mitophagy impairment-mediated thick ascending limb tubular cell inflammation and death to treat UMOD-related chronic kidney disease.